Integrating Risk Trajectories and Social Determinants to Enhance Cardiovascular Risk Assessment in Older Adults

PROJECT SUMMARY: Cardiovascular disease (CVD) is a leading cause of disability and death in the United
States; and the risks for disease are greatest among older adults. For more than half a century, CVD risk
calculators have been used to estimate a person’s risk of developing CVD and to guide treatment strategies to
prevent disease. Unfortunately, the tool recommended by current guidelines performs poorly in older adults and
among dis/advantaged population groups. The proposed reasons for these shortcomings are twofold. First, the
existing model does not account for changes in risk factors—e.g., cholesterol, blood pressure (BP), etc.—that
occur with age-related declines in vascular function and/or the use of preventive therapies. Second, the existing
model does not account for social determinants of health (SDOH) and other non-clinical factors that have been
shown to improve risk prediction across diverse population groups. Without addressing these issues, a vital
tool for CVD prevention will remain suboptimal and opportunities to reduce the development of CVD in adults
who are at greatest risk of disease will remain urgent and unmet. Our central hypothesis is that CVD risk
prediction and its translation to disease prevention can be greatly improved in older adults by synchronizing
age-related changes among multiple established risk factors while accounting for SDOH and other factors that
contribute to CVD risks. Using nationally-representative data (Health and Retirement Study [HRS]) and pooled
community-based cohorts (Atherosclerosis Risk in Communities [ARIC], Cardiovascular Health Study [CHS],
Multiethnic Study of Atherosclerosis [MESA], Framingham [FHS] Original, and FHS Offspring), our aims are
threefold: First, we will use group-based trajectory models to classify age-related changes within and among
the major risk factors for CVD in a nationally-representative sample of older adults (65+). Results will then be
validated with external (pooled cohort) data to identify the most efficient and robust classifications of age-related
changes among the multiple established risk factors. Second, we will predict the onset of CVD based on the
multi-trajectory profiles of risk factors. By accounting for changes in risk factors and trajectory group-membership
with advancing age, this approach will mirror a real-world clinical setting where follow-up measures become
available during routine care and a patient’s changes in risk factors translate into greater (or lesser) risks for a
CVD event. Third, we will examine a wide array of socioeconomic, psychosocial, and behavioral factors to
identify SDOH and other key factors related to individual risk profiles and CVD outcomes. The major aims of
this proposal are highly aligned with the National Institutes of Health’s (NIH) mission to better understand the
interdisciplinary dynamics of aging to prevent disease in older adults. Our study responds to this call by using
multiple datasets and innovative methods to optimize CVD risk assessment in older adults. With this integrated
new knowledge, our study will have significant potential to better inform the design, targeting, and timing of
clinical interventions to improve the primary prevention of CVD in a diverse and aging U.S. population.

Public health relevance
PROJECT NARRATIVE Cardiovascular disease (CVD) is a leading cause of disability and death among U.S. older adults and represents an enormous public health burden. Although CVD risk assessment is recommended as the foundation to primary prevention and guiding treatment decisions, the current tool for risk assessment performs poorly in older adults and among disadvantaged population groups. We propose to address these limitations by incorporating changes in risk factors over time and integrating social determinants of health to improve CVD risk-prediction and its translation to disease prevention in U.S. older adults.